METABOLIC STUDIES--MUSCLE PROTEIN SYNTHESIS IN NEUROMUSCULAR DISORDERS

Muscle protein synthesis, muscle carbohydrate metabolism, and the effects of insulin and growth hormone in myotonic dystrophy are under study using insulin clamps, forearm perfusion, and stable isotopes.